Administrative and Data Analytics Core A

ADMINISTRATIVE AND DATA ANALYTICS CORE A SUMMARY
The primary goal of the Administrative and Data Analytics Core is to enhance the research environment and
infrastructure in pursuit of building on the strong synergy between Project Leaders, Core Directors, and all
investigators to ensure cost effective management and integration of the goals of the PPG. The Program Project
Grant funding mechanism is designed to enhance collaborative research and dissemination of new information
that would otherwise not occur. The Administrative and Data Analytics Core has four major aims or
responsibilities. The first is to foster scientific progress and coordination among the various projects and cores,
including professional development and expansion of ideas. This includes coordination of scientific activities,
communication, and travel for the external advisory committee members, organizing and overseeing regular
scientific meetings of the entire research team. These services will be available to all investigators participating
within the framework of the PPG and are designed to improve efficiency, prioritization, resource management
and productivity of the individual projects and maximize the opportunity for synergism among projects and cores.
Secondly, the Administrative and Data Analytics Core will facilitate the various budgetary and business
requirements associated with the PPG. The PPG has the full support of the administration of the sponsor
institution, University of Alabama at Birmingham, and subcontract institution, University of Iowa. Thirdly, the
Administrative and Data Analytics Core will provide the infrastructure for a Biorepository to store samples and
data to facilitate future synergistic and collaborative studies with a state-of-the-art data management system.
Finally, the Administrative Core will provide biostatistical and bioinformatics expertise for each of the projects to
analyze data in standardized and novel approaches.

Public health relevance
ADMINISTRATIVE AND DATA ANALYTICS CORE A NARRATIVE The primary goal of the Administrative and Data Analytics Core is to enhance the research environment and infrastructure in pursuit of building on the strong synergy between Project Leaders, Core Directors, and all investigators to ensure cost effective management and integration of the goals of the PPG. The major functions of the Administrative Core include fostering scientific progress and coordination, promoting professional development, facilitating administrative and budgetary requirements, a biorepository with sample and data management as well as providing statistical and informatics resources, in order to accomplish the scientific mission of the PPG.